Defining vaccine immunogenicity and adoptive transfer in hematopoietic stem cell transplant recipients

PROJECT SUMMARY
Allogeneic hematopoietic stem cell transplant (HCT) recipients are at high risk of severe morbidity and
mortality due to respiratory viral illnesses, including COVID-19. Despite two mRNA SARS-CoV-2 vaccines that
are highly effective for the general population, HCT recipients have reduced immune responses to vaccines
and remain at risk. This population’s ongoing risk is amplified by the emergence and circulation of SARS-CoV-
2 variant strains, relaxation of mask mandates and other public health measures, and waning effectiveness of
SARS-CoV-2 monoclonal antibodies. New vaccination strategies are urgently needed for patients with
hematologic malignancies, both to protect these patients and to reduce viral reservoirs that otherwise would
allow for generation of new variants. To inform these strategies, we will evaluate the unique role of adoptive
transfer of humoral and cellular immunity in HCT recipients, which will simultaneously use vaccine response as
a mechanism to evaluate immune reconstitution. These studies will test our overarching hypothesis that these
patients have distinct and altered immune responses to mRNA SARS-CoV-2 vaccination, resulting from their
underlying disease, past immunomodulatory therapies, and the unique donor-to-recipient immune dynamics.
The Specific Aims of this proposal are: Aim 1: Characterize the relationship between donor and recipient
SARS-CoV-2 immunity in matched-related donor allogeneic HCT patients through analysis of humoral
responses and transfer of immunity post-transplant from banked samples; Aim 2: Describe the correlation
between donors’ pre-harvest cellular responses and recipients’ post-transplant humoral SARS-CoV-2 vaccine
responses through creation of a prospective study of HCT recipients and their matched-related donors; and
Aim 3: Evaluate donor v. recipient Ag-specific T and B cells and SARS-CoV-2 clonal breadth and depth after
re-vaccination post-transplant to assess immune reconstitution, using T and B cell receptor repertoire analyses
methods. We expect that completion of these aims and the associated training objectives will generate
clinically applicable preliminary data to inform vaccine development and policy for patients with hematologic
malignancies. My long-term career goal is to become an independently funded clinician-scientist and leader
in translational vaccinology with a focus on developing precision vaccines for immunocompromised adults. I
will achieve this through: 1) investigation of immunologic pathways that promote or inhibit vaccine-induced
responses for patients with hematological malignancies, and 2) translation of these findings into novel vaccines
via early-phase clinical trials. Brigham and Women’s Hospital and the Precision Vaccines Program at Boston
Children’s Hospital are highly collaborative research environments within the broader Harvard Medical School
community that will provide abundant resources and institutional support to complete the described aims.

Public health relevance
PROJECT NARRATIVE Due to reduced ability to create a strong immune response to SARS-CoV-2 vaccination or prior infection, individuals with hematologic malignancies remain susceptible to severe COVID-19 and can act as reservoirs that foster evolution of new SARS-CoV-2 variants, which threaten public health beyond this vulnerable population. This career development award will use blood samples from an existing cohort study and develop a new prospective study in stem cell transplant recipients to define immune profiles and assess the role of adoptive transfer of vaccine-induced immunity. Findings from these studies will lead to improved vaccination schedules and will be used to inform further research to develop targeted vaccines against respiratory viruses for immunocompromised individuals.